Engineering a Human Microphysiological System for the Characterization of Islet-Immune Interactions

Summary
Three dimensional (3D) microphysiological systems (MPS) represent a powerful intermediate model system
employing human cells and tissues capable of bridging in vitro studies and clinical trials. We propose to create
an integrated MPS platform to more accurately model the complex cellular interactions involved in human type
1 diabetes (T1D) pathogenesis. We previously generated an MPS containing novel extracellular matrix
hydrogels that support sustained islet function and T cell migration along the islet cell surface in 3D (CHIB),
and in first-of-their-kind studies, we demonstrated antigen-specific IGRP-reactive human CD8 T cells resulted
in targeted β-cell killing (CMAI). Here, we propose an interdisciplinary effort to integrate and expand the MPS
platform (referred to as the islet-immune Chip (iiChip)), as well as the cell-based technologies facilitating
testing of antigen-specific T cells, isogenic cellular systems capable of deriving multiple cellular lineages, and
genome editing technologies for use by the broader HIRN community. Specifically, we will utilize islets or islet-
like spheroids, endothelial cell monolayers, and innate and adaptive immune cells, including dendritic cells
(DCs), macrophages, CD4+ conventional T cells (Tconv), CD8+ cytotoxic T cells (CTLs), and regulatory T cells
(Tregs), to model the spatial configuration and complex cellular interactions involved in human T1D
pathogenesis. We hypothesize that this optimized 3D iiChip will facilitate in situ interrogation of Ag-
specific and genotype-phenotype interactions that are essential in T1D pathogenesis as well as the
mechanistic effects of immunomodulatory therapies with spatial and temporal control. Experimental
deliverables will include the ability to assess islet:immune interactions utilizing real-time high-resolution
imaging and quantitation of cellular interactions, trafficking, extravasation, and β-cell function/survival. Key
features of the iiChip will involve the integration of in-line sensors and bioreporters, spatial and temporal control
of inputs for defined stimulation, and integration of matrices with the capacity for fluidic and cellular
recirculation, measurement of soluble and cellular readouts in long-term cell culture. In addition, gene edited
induced pluripotent stem cells (iPSC) from male and female donors with T1D-risk associated HLA will be
available for the generation of immune, endothelial, and endocrine cells that are essential for building an
isogenic “disease-on-a-chip” model. When loaded with primary human cells or isogenic iPSC-derived materials
(i.e., endothelial, immune, and β-cells), this iiCHIP will enable dynamic interrogation of genotype-phenotype
interactions, antigen-specific β-cell killing, and effects of immunomodulatory therapies within a fluidic 3D
microenvironment. The iiChip will enable mechanistic studies capable of expediting clinical interventions aimed
at inhibition of immune-mediated β-cell destruction, enhancing immune regulation, and testing of β-cell
restorative therapies.

Public health relevance
Project Narrative Three dimensional (3D) microphysiological systems (MPS) represent a powerful intermediate model system capable of bridging in vitro studies and clinical trials. We propose to create an integrated MPS platform to more accurately model the complex cellular interactions involved in human type 1 diabetes (T1D) pathogenesis. This effort will integrate prior efforts of CMAI and CHIB investigators to create an integrated islet:immune interface, referred to as the iiCHIP, employing technologies that facilitate testing of antigen-specific T cells, isogenic cellular systems capable of deriving multiple cellular lineages, and genome editing technologies to enable mechanistic studies capable of expediting clinical interventions aimed at inducing immune regulation and β-cell restorative therapies.